The necessity of mitochondrial MDH2 for GABAergic neuron metabolism

Project Summary
Mitochondrial dysfunction is a well-established cause of neurologic and psychiatric disease. The brain is the
body’s most energetically demanding tissue and is especially vulnerable to metabolic challenges such as
hypoglycemia, ischemia, and mitochondrial disease. One such mitochondrial disease is caused by defects in the
mitochondrial enzyme MDH2, which catalyzes the final step in the TCA. Patients with mutations in MDH2 develop
infantile encephalopathy and epilepsy. The association between mitochondrial dysfunction and neurologic
disease is often attributed to a deficiency in ATP. However, in addition to ATP, the mitochondrial TCA generates
biosynthetic intermediates like α-ketoglutarate (α-KG) which is used to synthesize the neurotransmitter gamma-
aminobutyric acid (GABA). GABA is the brain’s primary inhibitory neurotransmitter, and decreased GABA
signaling underlies neurologic and psychiatric disorders such as major depressive disorder, anxiety disorders,
schizophrenia, autism spectrum disorder, and epilepsy. The research proposal aims to elucidate the critical role
of mitochondrial MDH2 in ATP and GABA production within GABAergic neurons. The hypothesis predicts that
MDH2-deficient GABAergic neurons can produce adequate ATP through glycolysis but fail to synthesize GABA,
leading to impaired GABA signaling without neuron death.
The proposal tests the hypothesis with two specific aims. The first aim investigates whether MDH2 is
essential for ATP production in GABAergic neurons. This involves studying the bioenergetic consequences of
MDH2 loss in human iPSC-derived GABAergic neuron cultures and a mouse model with MDH2 selectively
knocked out in GABAergic neurons. The second aim explores the necessity of MDH2 for GABA synthesis using
techniques such as metabolomics, RNA sequencing, isotope tracing, and spatial metabolomics. Additionally, the
proposal examines the potential of α-ketoglutarate (α-KG) as a supplementary substrate for GABA synthesis to
mitigate MDH2 deficiency. This research seeks to uncover the metabolic requirements for GABAergic signaling,
providing insights into the connection between mitochondrial dysfunction and GABA-related diseases, and
paving the way for new therapeutic strategies targeting GABAergic neuron metabolism.

Public health relevance
Project Narrative Mitochondrial dysfunction is implicated in the pathophysiology of many neurologic and psychiatric disorders. In addition to ATP, mitochondria produce biosynthetic intermediates through the TCA that are used to make neurotransmitters like glutamate and GABA. This project tests whether inhibition of the mitochondrial TCA prevents the production of GABA, the brain’s primary inhibitory neurotransmitter, impairing GABAergic signaling.